Technology Identification and Training Core

The goal of the Technology Identification and Training Core is to develop a Science of Translation of Artificial
Intelligence (Al) for Older Adults by developing processes that identify and articulate the needs of older adults
and their family caregivers, connect those needs to promising areas of Al technology, and accelerate the
refinement of these opportunities into tangible products than can be translated into practice. The Technology
Identification and Training Core plays two key roles: (1) it is the internal mechanism that that shapes the framing
of promising technology opportunities that, in turn, drive the solicitation and funding of pilots, and (2) it
disseminates the knowledge and mechanisms developed throughout this process to increase the awareness of
the opportunities for Al innovation addressing the needs of older adults and their family caregivers through
research and education programs. The specific aims of the Technology Identification and Training Core are 1)
To convene experts in Al and in Aging Research to develop and apply a stakeholder-informed Al
Readiness Framework {AIRF) to identify promising technology directions to support older adults' and
caregivers' needs. In collaboration with the Stakeholder Engagement Core, and guided by a participatory
ergonomics approach. We will achieve this aim by convening stakeholders and by developing stakeholder-informed
conceptual frameworks outlining key domains of older adults' and caregivers' technology needs to
support optimal well-being and resilience. We will also conduct structured identification and assessments of Al
suitability and maturity to meet the needs identified, 2) To create in-person and on line training tools that both
exploit and expand our knowledge of the Implementation Science for Al, and 3) to develop and deploy
instructional tools that describe Science of Translation of Artificial Intelligence {All for Older Adults and
related best practices for wider use and dissemination. Successful completion of these aims will provide a
process for building on stakeholder-informed principles and develop a platform for continuously updated needs
assessment and technology readiness assessment instruments that will support a national program to tailor Al
to address the needs of older adults and their family caregivers. The current proposal will address and fill key
knowledge gaps and directly engage stakeholders in co-design efforts. The transdisciplinary research team is
poised to complete the specific aims that will result in identification of older adults' needs related to wellbeing
and resilience, characterization of risks to older adult safety from multiple perspectives, and the refinement of a
process that will enable healthcare systems and engineers to identify and design technology to address older
adults' and caregivers' needs. In doing so, the current proposal directly facilitates technology development to
allow older adults to thrive.